Diet and the neurodevelopment of impulsivity

Project Summary
Impulsivity refers to the propensity toward rapid action without forethought of the consequences and
devaluing rewards that are delayed in time in favor of immediate gratification. Food impulsivity is associated
with obesity and binge-eating disorder and can counter efforts to make healthy food choices. Regions of the
brain that regulate food impulsive behaviors, such as the hippocampus and medial prefrontal cortex (mPFC),
undergo neuroplasticity during adolescence and emerging evidence indicates that hippocampal-dependent
memory is vulnerable to the deleterious impact adolescent consumption of “Western diets” (WD) high in
saturated fat and added sugars. Furthermore, hippocampal dysfunction associated with adolescent WD
consumption is not easily reversible by switching to a healthy diet during adulthood. We propose that
adolescent consumption of a WD impairs hippocampal development leading to increased impulsive eating
behavior during adulthood. Our unpublished preliminary data are consistent with this hypothesis and show
that female rodents fed a WD during adolescence have increased impulsive actions when responding for a
palatable food reinforcer during adulthood. Proposed work will extend this model to males and will also
determine whether females and males on a WD during adolescence show a propensity to select smaller and
more immediate food rewards over waiting for a larger payoff (delay discounting test of impulsive choice). Our
additional preliminary in vivo calcium imaging data reveal differential calcium dynamics in the ventral CA1
hippocampus (vCA1) prior to impulsive vs. non-impulsive food-directed action, with analogous effects
observed in the nucleus accumbens shell (ACBsh). Building off these findings, we propose to determine how
specific hippocampal circuits (vCA1->mPFC and vCA1->ACBsh) known for their role in modulating reward
behaviors, inhibitory control, and impulsivity, are impacted by an adolescent WD consumption in rats. To
determine whether behavioral intervention can reverse the long-lasting increased food impulsivity associated
with adolescent WD, we will also investigate whether aerobic exercise, which is known to attenuate WD-
induced hippocampal-dependent memory impairments, can attenuate adolescent WD-induced food impulsive
actions and choices. Further, we have previously shown that the incretin hormone glucagon-like peptide-1
(GLP-1) acts on a vCA1->mPFC pathway to reduce food impulsive behavior. Thus, here we propose to
determine whether clinically relevant FDA-approved GLP-1 analogue treatment reverses or attenuates
adolescent WD-induced food impulsive behaviors. This proposal is sufficiently powered to determine sex
differences for all experiments, and results from these studies will provide a critical contribution to obesity
developmental neuroscience research and advance our understanding of how diet impacts eating behaviors.

Public health relevance
Project Narrative Consumption of a Western Diet, high in saturated fat and sugar, during the adolescent phase of development impairs hippocampal-dependent learning and memory function during adulthood. The hippocampus is also known to regulate aspects of food intake control that are relevant for obesity, including impulsive behaviors to obtain and consume palatable yet otherwise unhealthy food. We propose to determine the impact of an adolescent Western Diet on food impulsive behavior, identify the neurobiological circuits involved, and determine whether the impact of the diet can be reversed by exercise and/or treatment with a GLP1R agonist.